Effective MS-Based Methods for Unraveling Cell Surface Protein Interactions

SUMMARY
The surface of mammalian cells contains many important proteins including receptors and transporters. They
regulate numerous cellular events, such as sensing extracellular nutrients, and initiating cell signaling.
Frequently, these proteins do not work independently, but cooperate with one another instead to fulfill the tasks.
Aberrant protein interactions on the cell surface will impact protein activities and result in human diseases such
as cancer. Therefore, it is not sufficient to identify and quantify surface proteins. Systematic investigation of
surface protein interactions can aid in an in-depth understanding of protein functions and cellular activities, and
provide insights into the molecular mechanisms of human diseases. However, it is extraordinarily challenging to
comprehensively analyze protein interactions only on the cell surface. The objective of this project is to develop
innovative and effective methods to globally analyze protein interactions on the cell surface, especially direct
interactions among low-abundance surface proteins, and apply the methods to study surface proteins and their
interaction changes during the epithelial-to-mesenchymal transition (EMT). Guided by strong preliminary data,
this objective will be fulfilled by pursuing three specific aims. 1) Effective MS-based methods for global analysis
of protein interactions on the cell surface. Through the development of the innovative methods, surface protein
interactors will be systematically analyzed. The cleavable cross-linker with a chemical handle will allow for
selective enrichment of cross-linked peptides, which will enable us to identify many more direct interactions
among low-abundance surface proteins. Furthermore, integrating cleavable detergents into the workflow will
increase the coverage of membrane proteins on the cell surface. 2) Radical chemistry-based methods to tag
surface proteins for studying their interactions. Based on the fact that the cell surface is covered with glycans,
radicals will be generated through the enzymatic oxidation of glycans, and they will be used to quickly tag surface
proteins. Radical chemistry-based methods will further increase the coverage of surface proteins and their
interactions. More comprehensive analysis of surface proteins and their interactions on the cell surface will be
achieved. 3) Quantification of surface glycoproteins and the surface protein interaction remodeling during the
EMT. During the EMT, the properties of cells change dramatically, such as cell morphology, cell-cell interactions,
and cell mobility, which are often determined by surface proteins. The proposed methods will be applied to
comprehensively analyze surface glycoproteins and the surface protein interaction network remodeling during
the EMT. The results will unveil the molecular mechanisms of the EMT and the EMT-relevant diseases. Without
sample restrictions, the proposed methods can be extensively applied to study surface protein interactions,
leading to the identification of surface proteins as disease biomarkers and drug targets.

Public health relevance
Narrative: The proposed research is relevant to public health because the novel methods will allow us to comprehensively analyze surface protein interactions. Considering the importance of surface proteins, the innovative method will be extensively applied to biomedical research for advancing our understanding of protein functions and the molecular mechanisms of human disease, which will lead to the discovery of surface proteins as effective biomarkers for disease detection and novel drug targets for disease treatment. Thus, the proposed research is relevant to the portion of NIH’s mission that pertains to seeking fundamental knowledge that will enhance health, lengthen life, and reduce disability.